SREBP1 as a Novel Mammalian Oxygen Sensor

ABSTRACT
Millions of people in the United States have cardiopulmonary diseases marked by chronic hypoxia, a persistent
reduction in oxygen availability and delivery to cells and tissues. In patients with diseases such as severe chronic
obstructive pulmonary disease or advanced heart failure, chronic hypoxia is associated with increased morbidity
and mortality. Little is known about how cells and tissues sense and adapt to chronic hypoxia. This proposal
outlines a five-year K08 Mentored Clinical Scientist Research Career Development Award that will address this
question and prepare me to become an independent physician-scientist with a focus on oxygen metabolism, lipid
homeostasis, and cardiovascular disease. My goal in seeking this career development award is to acquire the
robust knowledge and technical expertise I need to uncover the mechanisms of oxygen sensing and adaptation
in mammals, which will open new therapeutic avenues to alleviate the impact of chronic hypoxia.
I hypothesize that sterol regulatory element-binding protein 1 (SREBP1), which is a basic helix-loop-helix leucine
zipper transcription factor, is an evolutionarily conserved oxygen sensor that mediates organismal adaptation to
chronic hypoxia by monitoring oxygen-dependent changes in lipid saturation as an indirect measure of low
oxygen availability. My preliminary data show that remnants of the yeast SREBP1-dependent oxygen sensing
pathway are present in mammals and that SREBP1 is activated in chronic hypoxia. I hypothesize that SREBP1
promotes the transcription of genes that allow for cellular adaptation to chronic hypoxia by binding to various
promoter regions, including hypoxia response elements and E-box domains (Aim 1). I also hypothesize that the
oxygen sensing mechanism of SREBP1 is mediated through changes in fatty acid desaturation in chronic
hypoxia (Aim 2). Finally, I hypothesize that SREBP-1c is a critical mediator of fatty acid uptake and utilization in
the liver as mechanism to restore lipid homeostasis in chronic hypoxia (Aim 3).
This research training will be conducted under the mentorship of Dr. Isha Jain, an oxygen metabolism expert
who demonstrated the therapeutic potential of hypoxia for mitochondrial disease, with co-mentorship from Dr.
Robert Mahley, an expert in lipid biology and cardiovascular and neurological diseases with a long track record
of mentorship. I have assembled a team of highly accomplished advisors with expertise in hypoxia signaling in
C. elegans, SREBP biology, lipid metabolism, and functional genomics. My training plan has been carefully
structured to provide me with mentorship and robust research training in advanced techniques in molecular
biology, bioinformatics, systems biology, and animal models of disease. My development plan will help me gain
important skills in laboratory management, leadership, and scientific communication. Completing the research
training program and obtaining the skill sets outlined in this K08 career development award will lay the foundation
for my career as an independent, R01-funded physician-scientist.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE STATEMENT Chronic hypoxia affects millions of patients with cardiopulmonary diseases such as advanced heart failure and severe chronic lung disease, and is associated with increased morbidity and mortality. The goal of this work is to test the hypothesis that the transcription factor, sterol response element binding protein 1 (SREBP1), is an evolutionarily conserved oxygen sensor in mammals that mediates adaptation to chronic hypoxia by integrating changes in lipid metabolism and low oxygen availability. This work could uncover novel therapeutic targets for conditions that lead to long-term hypoxia, in particular cardiovascular and metabolic diseases.